VDH Laboratory Food Testing Capability and Capacity Enhancement Project

Project Abstract Summary
The Vermont Department of Health Laboratory (VDHL) is located at 359 South Park Drive in
Colchester, VT. The mission of VDHL is to promote health and prevent disease by providing
quality analytical services, leadership in laboratory science and support to public health and
environmental activities. VDHL, as the primary servicing laboratory, is committed to
strengthening the food safety system in Vermont by supporting the regulatory and surveillance
activities of the Vermont Department of Health Food and Lodging Program (VDHFL), which
holds the State Manufactured Food Regulatory Program contract with FDA. To support these
activities, VDHL must maintain and enhance its ISO/IEC 17025 accreditation, obtained in
September 2016, to ensure all test data generated is valid and defensible. VDHL is requesting
funds in the amount of $1,884,472 to be used from July 2020 through June 2025 to maintain
and enhance its ISO/IEC 17025 accreditation, increase its food sampling and testing capacity,
develop a validated method for gamma emitting radionuclides in human food, and report all
collected surveillance data to FDA. Some specific uses of the funds include hiring two new
Public Health Laboratory Scientists, buying key equipment, traveling to face-to-face meetings to
share cutting edge ideas, and verifying new methods through special projects. Through this
partnership, an increase in the number and type of laboratory analyses conducted will lead to
enhanced protection of the food supply through an integrated food safety system.

Public health relevance
NARRATIVE The Vermont Farm to Plate Network’s Rooted in Vermont grassroots initiative has increased locally sourced food purchases from 6.9% in 2010 to 12.9% in 2018 (representing more than $289 million in local food sales) and aims to mainstream local food consumption in Vermont during the next decade. At the same time, the Centers for Disease Control and Prevention (CDC) estimates that 1 in 6 Americans (or 48 million people) get sick, over 128,000 are hospitalized, and 3,000 die from contaminated foods or beverages each year and the United States Department of Agriculture (USDA) estimates that these foodborne related illnesses cost over $15.6 billion dollars each year. The Vermont Department of Health Laboratory (VDHL) attained ISO/IEC 17025 accreditation in September 2016 and is the primary serving laboratory for the VDH Manufactured Food Regulatory Program Standards (MFRPS) and is seeking funding to maintain and enhance its ISO/IEC 17025 accreditation, increase its microbiological and radiochemical food sample testing capacity and capabilities, increase its data sharing and surveillance capabilities, and overall capacity to protect Vermonters from unsafe food supplies.